CCSG Supplement: To Enhance the Utility of Data Available through the Childhood Cancer Data Initiative (CCDI) Ecosystem

P30 _ CCDI_Data UseSupplement
TITLE: Pilot study to link clinical and imaging data from the electronic medical record (EMR),
Children's Brain Tumor Network (CBTN) and the Molecular Characterization Initiative (MCI).
ABSTRACT:
The launch of the Molecular Characterization Initiative (MCI) provides an unprecedented
resource of molecular data on children with newly diagnosed cancers, including over 1000
participants with primary tumors of the central nervous system (CNS) in the first year. The
Children's Brain Tumor Network (CBTN) is a consortium of institutions committed to genomic
characterization and clinical data collection and sharing through open access platforms. The
CBTN has collected longitudinal clinical and biological data on over 5000 participants with CNS
tumors over the past decade, data which is shared in open cloud-based platforms. Seattle
Children's Hospital as part of the Fred Hutch/UW comprehensive cancer center is uniquely
positioned as a founding member of CBTN and the highest enrolling site on MCI to conduct the
pilot study proposed to 1) develop a pipeline to automate data extraction from the electronic
medical record in partnership with CBTN and Amazon Web Services (AWS) teams, 2) increase
imaging data available through CBTN and CCDI and 3) connect CBTN and MCI data at the
participant level. The tools, processes and pipelines developed in this pilot may be rapidly
expanded to other institutions to greatly increase the impact of the CCDI as a rich resource for
the pediatric cancer research community.

Public health relevance
P30 _ CCDI_Data UseSupplement TITLE: Pilot study to link clinical and imaging data from the electronic medical record (EMR), Children's Brain Tumor Network (CBTN) and the Molecular Characterization Initiative (MCI). PROJECT NARRATIVE: We propose to conduct a pilot study in partnership with Amazon Web Services (AWS) and Children's Brain Tumor Network (CBTN) operations teams to 1) develop a pipeline to support automatic data extraction from the electronic medical record, 2) increase imaging data available through CBTN and CCDI and 3) connect MCI and CBTN data at the participant level.